CENTRAL EFFECTS OF PERIPHERAL HEARING IMPAIRMENTS

Almost any peripheral hearing loss results in some atrophic effects of auditory portions of the brainstem. The proposed morphological experiments will use experimental mice and guinea pigs to determine: 1) If the dendrites of ventral cochlear neurons are adversely affected by neonatal auditory deprivation, neonatal conductive losses, and/or neonatal cochlear removal; 2) If there is a direct correlational relationship between cochlear atrophy and ventral cochlear nuclear atrophy in deafness mice (dn/dn); 3) If ganglioside tratment can ameliorate transneuronal atrophy in hearing impaired mice and guinea pigs; 4) If there are quantitative and/or qualitative differences in the cochlear nuclei of mice with long-term cochlear removals starring neonatally as compared to those starting in adult mice; and 5) If there are dramatic short-term effects of cochlear removals in mice as there are in chicks. The results of these experiments will document the age-dependent, transneuronal, atrophic effects of peripheral hearing impairments and explore means of ameliorating them.